Healing enterocutaneous fistulas using bioengineered biomaterials

Abstract
Enterocutaneous fistula (ECF) is an abnormal connection between the bowel and skin. It can be associated with
discharge of pus, feces, and stomach contents and can even lead to incontinence. ECFs are referred to as
surgical tragedies in the literature, as up to 85% are the result of intraabdominal surgical complications, such as
missed enterotomies or anastomotic leaks. This can lead to constant leakage of enteric and fecal contents from
the skin, sometimes up to many liters per day. The foul enteric contents act as a chemical irritant to the skin,
leading to skin breakdown and predisposition to infection. Despite advances in treatment, ECFs still account for
significant mortality of 15-20% and are associated with debilitating morbidity and substantially poor quality of life
due to complex wound care, severe malnutrition, frequent infectious complications, pain, and depression.
Despite advances in surgical techniques and postoperative management, no successful treatment of ECF exists
today. The current treatment paradigm is unsuccessful; high fistula discharge, infection, and chronic
inflammation lead to high failure and recurrence rates. This often results in prolonged intensive care unit (ICU)
stays increasing health care cost which can be over $500,000 per ICU visit. We hypothesize that by using a
bioengineered biomaterial that is biocompatible, non-toxic, durable, antimicrobial and regenerative, we would
change the standard of medical practice in the approach to ECF. This creative approach may reduce world-wide
morbidity and mortality by successfully occluding and healing any ECF, preventing fecal leakage; it will also
substantially improve the quality of life of the patient and reduce the need for repeated interventions and X-ray
imaging. We aim to make a paradigm shift in the treatment of potentially fatal ECF using a minimally invasive
blood-derived biomaterial-based platform to occlude the fistulous tract using groundbreaking injectable shear-
thinning platelet-rich gels. We will engineer the blood derived biomaterial to include antimicrobial, adhesive, and
regenerative components that will be tested in vitro and in vivo (Aim 1) and we will evaluate the optimized
biomaterial with established rodent fistula models (Aim 2). Finally, we will test theses engineered biomaterials in
a porcine ECF model to promote aseptic healing of fistulas (Aim 3). We will evaluate healing trajectories of the
fistulas using clinical observation, fluoroscopy, ultrasound, micro-CT, histology, Helios mass cytometer analysis
of the cellular populations and the Hyperion imaging technology to evaluate up to 37 biomarkers on slides and
RNA sequencing.

Public health relevance
Narrative Enterocutaneous fistula (ECF) is an abnormal connection between the bowel and skin. It can be associated with discharge of pus, feces, and stomach contents and can even lead to incontinence. The foul enteric contents act as a chemical irritant to the skin, leading to skin breakdown and predisposition to infection. The current treatment paradigm is unsuccessful; high fistula discharge, infection, and chronic inflammation lead to high failure and recurrence rates. We aim to offer a solution in the treatment of potentially fatal ECF using a minimally invasive blood derived biomaterial-based platform to occlude the fistulous tract using groundbreaking injectable shear- thinning biomaterials with anti-microbial and regenerative properties.